A High-Throughput Platform for COVID-19 Serodiagnosis, Vaccine Evaluation, and Drug Discovery

ABSTRACT In response to the current COVID-19 pandemic, it is of paramount importance to rapidly diagnose infections and to develop countermeasures. This project aims to build a high-throughput platform for rapid COVID-19 serodiagnosis, vaccine evaluation, and therapeutics development.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The ongoing SARS-CoV-2 has caused global pandemic. Rapid response to disease control and countermeasure development is a public health priority. The development of a high-throughput platform is a top priority for rapid COVID-19 serodiagnosis, vaccine, and antiviral R&D.